Improving longitudinal mental health monitoring to generate personalized guides and timely referrals

This proposal addresses the need for a scalable and engaging method for patients to track their mental health
so they can receive high-quality, effective, and patient-centered care recommendations and referrals. It aims to
decrease the ~50% gap of untreated mental illness3 and shorten the average decade-long time to care2 from
symptom onset to days-weeks. Tracking a patient’s progress can help assess the effectiveness of treatment,
lead to timely adjustments, facilitate early identification of adverse events or complications, improve
communication between patient and provider, and provide a comprehensive view to understand long-term
patterns and outcomes of treatment. Until now, there has not been a good way to simultaneously track, triage,
and tailor appropriate mental health recommendations and referrals cohesively and automatically. The
for-profit MiResource will partner with the non-profit Child Mind Institute (CMI) to address this gap by
integrating separate software solutions, curating comprehensive guides on mental health topics, and using AI
to generate personalized guides. CMI has clinical experts to help select appropriate assessments, edit guides,
and evaluate the relevance of guides and referrals. For over a decade, CMI’s editorial staff has composed over
1,000 highly accessed, online, freely available mental health articles and guides that will serve as one of the
sources of guides for the project. CMI has developed a configurable mobile mental health platform called
MindLogger, which has already been integrated into MiResource’s platform through an Application
Programmer Interface to administer assessments. CMI is also developing a mental health database and
recommender system called Mosaic and a multimodal journaling app called Mirror, all of which are well-suited
to the assessment and recommendation components of the project. MiResource provides the referral
infrastructure, a software-as-a-service solution designed to help connect people to local mental health
providers and programs, and a network of 70 US colleges that use MiResource for their students. Goal: Build
a scalable, personalized, user-friendly, and expert-informed digital ecosystem for continuous
journaling and assessment, guidance, and referral for adolescents and college-age students. A
combination of mobile apps, an online provider directory, and AI-personalized guides will automate triage,
tracking, and tailored recommendations and referrals. Phase I will (Aim I-1) build longitudinal assessments to
monitor therapeutic progress and automate referrals; (Aim I-2) create a standard format for generating
comprehensive mental health guides; and (Aim I-3) integrate assessment, journaling, recommendation, and
referral software as a unified mental health platform. Phase II will (Aim II-1) build comprehensive mental health
guides in Aim I-2’s format, manually curated by content experts; (Aim II-2) generate personalized guides in Aim
I-2’s format using AI and based on journal entries; and (Aim II-3) clinical experts and participants evaluate
AI-generated, personalized guides and referrals to ensure clinical relevance of Aim I-3’s integrated platform.

Public health relevance
NARRATIVE Most adolescents and college-age students are not receiving necessary mental health care, do not have a way to find mental health providers, track progress between appointments, assess the efficacy of treatment, and receive support early to prevent complications or adverse events. The proposal is to build and evaluate an online and mobile platform for journaling, assessment, guidance, and referral by integrating and refining platforms specializing in each of these functions, with personalized guides generated by AI that draw from manually curated, comprehensive source guides on different mental health topics to ensure recommendations are relevant. Evaluation will cover the integrated platform’s referral recommendations and the quality and relevance of AI-generated, personalized guides based on feedback from 1,000 users and clinical experts.